Enhancement of California's Integrated Food Safety and Security System: Discipline D Track3

Project Summary/Abstract: Discipline D, Track 3 FDA LFFM (U19), FOA PAR-20-105 The primary goal of this project under Discipline D Track 3 (Method Development / Validation) is to contribute to the validation of new analytical methods or matrices for food testing by participating in the multi-laboratory and single-laboratory validation of chemical analysis methods requested FDA. The method validation activities will be conducted following the guidelines published by FDA FVM Program. Food and Drug Laboratory of CDPH is capable of taking part in a variety of possible methods and matrices that include immunochemical-based kits for histamine, ICP-MS for arsenic speciation and general metals in seafood and drinking water, and LC/MS/MS for veterinary drug residue in dairy or meat products and pesticide residue in food. The adoption of the new test methods will strengthen and improve the food testing toolbox and enhance the existing food safety and security program both locally and nationally.

Public health relevance
Project Narrative: Discipline D, Track 3 FDA LFFM (U19), FOA PAR-20-105 The proposed special project of method development and validation will contribute to the creation of new food testing methods for the determination of toxic metals, seafood toxins, veterinary drug residue, and pesticide residue in food products, through multi-laboratory or single laboratory validation of methods following the guidelines from FDA FVM program. The adoption of the new test methods will strengthen and improve the food testing toolbox and enhance the existing food safety and security program both locally and nationally.